Maternal health in pregnancy and autism risk - genetic and non-genetic mechanisms - Administrative Supplement

PROJECT SUMMARY
No change from original submission

Public health relevance
PROJECT NARRATIVE No change from original submission